In situ functional genomics to understand transcriptional regulation

In situ functional genomics to understand transcriptional regulation
In the last 3 years, new gene editing technologies have revolutionized our ability to manipulate the human
genome for basic research and for disease modeling. Targeted gene knock-out and precision gene repair —
previously laborious or impossible tasks in human cells — are now routine. Despite these advances in genome
surgery, much of how the genome is translated into phenotype remains a mystery and the most mysterious
regions are those in the noncoding genome. Unlike with protein-coding genes, there is no Central Dogma-like
framework to decipher how the noncoding genome functions. The goal of this proposal is to address a
fundamental problem in transcriptional regulation: How can we identify the sequences and proteins that govern
the expression of any gene, in an unbiased way?
Consortium efforts like ENCODE and the Epigenomics Roadmap have produced large catalogs of biochemical
hallmarks that correlate with noncoding function. However, correlation does not equal causation. Proving that
certain regions of the genome regulate gene expression or act as landing pads for DNA-binding proteins
requires unbiased mutagenesis and interrogation. In part, the problem has to do with size. The noncoding
genome is a vast expanse: Noncoding regions constitute >98% of the 3 billion DNA bases in the human
genome. We urgently need high-throughput, molecular microscopes capable of zooming in on functional
regions and recording how proteins interact at these loci. Given new advances in genome engineering and
high-throughput sequencing, we are in a prime position to understand the functional, gene-regulatory
architecture of the noncoding genome.
Here, we will apply our established expertise to examine functional regions of the noncoding genome in their
endogenous context. Using human cancer and stem cell lines as model systems, we will develop five broadly-
applicable cross-disciplinary platforms by harnessing recent advances in scalable DNA synthesis, genome
engineering, droplet cell capture, deep sequencing and quantitative proteomics and thereby enable: 1) higher
resolution noncoding CRISPR screens using Cas9 orthologs and 2) increased span (chromosome-scale)
noncoding CRISPR screens using the new Cas enzyme Cpf1; 3) multidimensional readouts of entire gene
networks by combining pooled mutagenesis with single-cell RNA-seq; 4) unbiased labeling of all transcription
factors stationed at functional elements identified in CRISPR screens via a novel Cas9-enabled proteomic
technology; and 5) applying this fleet of new technologies jointly to reveal dynamics of functional elements in
neural differentiation and cancer drug resistance.

Public health relevance
Project Narrative The human genome contains many regions that do not produce proteins but instead regulate the expression of genes that produce proteins. Mutations in these regulatory regions can interfere with normal gene function and lead to different diseases, such as cancer or brain disorders. Here we present a suite of new technologies to pinpoint regulatory regions within the genome, to recognize the genes they regulate and to identify the mechanisms they use to alter gene expression.